"Biting" of human cells by Entamoeba histolytica: a novel cytotoxic mechanism

DESCRIPTION (provided by applicant): I propose to study the pathogenesis of amoebic colitis, a global parasitic infection and a major source of morbidity and mortality of children. Entamoeba histolytica was named histolytica for its destruction of host tissues and invasion of the intestine, but the mechanism was unknown. I recently made the surprising discovery that amoebae kill by biting off and ingesting distinct pieces of living human cells, resulting in intracellular calcium elevation and eventual death. I named this trogocytosis-like ingestion (Greek, trogo-: nibble) due to similarity to trogocytosis in immune cells. I hypothesize that pathology in amoebic colitis results from parasites invading the intestine by nibbling the epithelial cells that line the gut. It is likely that the novel killing mechanism requires unique phagocytic machinery and that the components represent new drug targets. Therefore, I propose to uncover the signaling mechanisms underlying trogocytosis-like ingestion. Furthermore, I propose to re-examine the long-standing hypothesis that the E. histolytica pore-forming proteins, known as the amoebapores, are secreted cytotoxic effectors. Successful completion of this work will create a paradigm shift in the functio of the amoebapores, and will also allow us to identify novel virulence factors, ultimately allowing us to define the basic mechanism of disease.

Public health relevance
I propose to study the mechanism of pathogenesis of amoebic colitis, a major global parasitic disease. Entamoeba histolytica was named "histolytica" for its potent human cell killing activity and destruction of intestinal tissue. I will delineate the mechanism by which human cells are killed, thus these studies offer the promise of new approaches to prevent or treat this life-threatening infection, for which there is no vaccine and therapy is limited to a single class of agents.